CN-105 Improves Functional Outcome After Intracranial Hemorrhage

Annually, approximately 100,000 patients in the USA suffer from intracerebral hemorrhage (ICH), which is
associated with high mortality rates and poor long-term cognitive and physical recovery. At present, no
pharmacological therapies have been demonstrated to improve functional outcomes after ICH. However, we
have successfully demonstrated that CN-105, a pentapeptide derived from the receptor binding surface of the
apolipoprotein E (apoE), is a highly promising therapy for improving recovery after ICH. CN-105 was rationally
designed to mimic the LRP-1 receptor binding face of the apoE holoprotein, which binds the cell surface low
density lipoprotein-related (LRP1) receptor, reducing microglial activation, neuroinflammation, and neuronal
excitotoxicity. We demonstrated that CN-105 has excellent CNS penetration, is well tolerated, and retains the
anti-inflammatory and neuroprotective effects of endogenous apoE holoprotein.
In the Phase 1 of this STTR, we demonstrated CN-105's preclinical efficacy across species, sex, age, and
hypertensive comorbidity, as evidence to support efficacy phase clinical trials. Our preclinical work with CN-105
has led to the successful completion of an IND and translation to a Phase 1 single- and multiple-escalating dose
study (NCT02670824), where CN-105 demonstrated excellent clinical safety profile and linear pharmacokinetics.
Based on the successful completion of the Phase 1 trial and after consultation with and funding from the FDA,
we completed and recently published the CN-105 in participants from the Acute supraTentorial
intraCerebral Hemorrhage (CATCH) trial, a multisite open-label safety study in patients with acute ICH
(NCT03168581)1, which demonstrated early efficacy, and completed a parallel randomized placebo-controlled
clinical trial in patients with ICH in Singapore (S-CATCH; NCT03711903).
Together the CATCH and S-CATCH trials will allow insight into target engagement and therapeutic efficacy of
CN-105 via analyses of serologic proteins and radiographic surrogates. Given the orphan drug status of CN-
105, our preliminary data are critical to rationally inform the development of a larger and definitive ICH study. In
the current proposal, we will design an adaptive Phase 2b/3 clinical trial to evaluate CN-105 efficacy, in
collaboration with StrokeNet and the Duke Clinical Research Institute (DCRI) (Milestone 1). To form the basis
for trial adaptation, we will utilize radiographic and serologic data already collected in the completed CATCH and
S-CATCH trials to characterize an algorithm for screening treatment response to CN-105 (Milestone 2).

Public health relevance
Narrative Intracerebral hemorrhage (ICH) is a devastating stroke sub-type with no proven therapy. Based on strong supportive evidence and recent clinical trials, CN-105, a 5-amino acid peptide derived from the receptor binding surface of the apolipoprotein E (apoE), appears to be poised for translation as an acute ICH therapeutic. This project will build on prior our Phase 1 STTR by coupling use of blood proteins and brain imaging to improve patient selection for planning an Phase 3 clinical trial of CN-105 in acute ICH.